Mechanisms of MUC5AC Tethering and Hypersecretion in Asthma

PROJECT SUMMARY/ABSTRACT
Asthma is an airway obstructive disease that is a major cause of morbidity in the US and worldwide.
Approximately half of people with asthma present with type 2 high (T2-high) asthma, which is an endotype of
asthma commonly characterized by high levels of type 2 cytokines, such as IL-4 and IL-13, within the airway.
These cytokines induce airway epithelial remodeling, causing goblet cell hyperplasia. Goblet cells are
responsible for the production and secretion of mucus, and one hallmark of Th2-high asthma is mucus
hypersecretion and the development of mucus plugs within airways. The Erle lab has recently identified that IL-
13 stimulation in human bronchial epithelial cell (HBEC) cultures causes the overproduction of MUC5AC, and
also leads to MUC5AC “tethering”, where MUC5AC protein adheres to the apical surface of epithelial cells. This
tethering causes a significant reduction in mucociliary clearance (MCC), and is hypothesized to contribute to the
formation of mucus plugs in asthma patients. However, it is not yet known what changes induced by IL-13 lead
to mucus tethering. Recent RNA sequencing analysis of both IL-13 stimulated HBEC cultures and airway cells
from T2-high asthma patients revealed significantly elevated levels of CST1 and CST4, genes encoding for
Cystatin 1 (CST1) and Cystatin 4 (CST4), respectively. Cystatin proteins function as cysteine protease inhibitors,
but their role in airway epithelia function has not been characterized. Downstream functional analyses have
shown that deletion of either CST1 or CST4 rescues the IL-13-dependent loss in MCC, suggesting an important
role for both cystatins in T2-high asthma pathogenesis. The studies in this proposal seek to characterize the role
of CST1 and CST4 in T2-high asthma. CST1 and CST4 will be knocked out of HBEC cultures prior to IL-13
stimulation in order to determine how they influence mucin secretion, turnover, and/or tethering. In addition, we
will identify the endogenous cysteine proteases that are inhibited by CST1 and CST4, and use knockout and
overexpressing HBEC cultures to test if these cysteine proteases regulate MCC and mucus tethering. Finally, in
vitro enzyme assays and short-circuit current analysis of HBEC cultures will be used to determine if endogenous
cysteine proteases target MUC5AC and/or ENaC in order to regulate MCC. Understanding the mechanisms that
control mucus tethering and impaired MCC in asthma will provide fundamental insights into the progression of
the disease and could contribute to the development of future therapeutics for asthma patients. This proposed
project will be performed as part of a postdoctoral fellowship at UCSF and will utilize comprehensive institutional
support and resources in order to prepare the applicant for a research career.

Public health relevance
PROJECT NARRATIVE Asthma is an airway disease characterized by airway inflammation, mucus hypersecretion, mucostasis, and the eventual development of airway mucus plugs, which are the product of not only increased quantity of mucus, but a change to the mucus organization, including increased adherence, or “tethering”, of mucin proteins to the apical surface of airway epithelial cells. Findings from our lab have indicated that tethering and mucostasis is regulated by two cysteine protease inhibitor proteins Cystatin 1 and Cystatin 4. This proposal seeks to determine how these cystatin proteins and their cysteine protease targets regulate mucin tethering and mucociliary clearance in asthma in order to better understand how to combat airway mucus plug formation in asthmatic patients.